Research Training of Anesthesiology Physician-Scientists

Project Summary
The proposed program will provide support for postgraduate research training within the Department
of Anesthesiology at McGovern Medical School at the University of Texas Health Science Center at
Houston. Successful applicants will have committed to or be enrolled in postgraduate training
specifically in anesthesiology. The candidate pool is largely derived from an established research
residency track (Anesthesia Scholars Program). The program will provide for two trainees in the first
year, and three trainees in subsequent years. Trainees will typically be attending anesthesiologists
at the rank of Assistant Professor. Research opportunities are offered by twenty-one participating
faculty members with proven records of success in the training of postdoctoral fellows, both within
the Department of Anesthesiology as well as from nine collaborating departments, three in basic
sciences: Biochemistry and Molecular Biology, Integrative Biology and Pharmacology, and the
Medical Genetics division of Internal Medicine; and six clinical departments/divisions: Critical Care,
Gynecologic Oncology & Reproductive Medicine, Emergency Medicine, Rheumatology, Neurology,
and Neurosurgery. With the continued support from the Department of Anesthesiology following
completion of training, this program will encourage independent physician-scientists to move along
their career trajectories by implementing modern methods and techniques to help meet the research
needs of the specialty of anesthesiology in the twenty first century.

Public health relevance
Narrative The proposed program will provide support for postgraduate research training in the Department of Anesthesiology at McGovern Medical School as part of the University of Texas Health Science Center at Houston to qualified applicants who have committed to or are enrolled in postgraduate training in anesthesiology. The goal of this training is to provide the next generation of physician- scientists and researchers with the tools and training necessary for those who seek to improve medical care in areas relevant to perioperative care, palliative care, acute and chronic pain and health services delivery.